Defining Therapeutically Targetable Regulators of Tumor-Intrinsic Immune Suppression in Glioblastoma

Glioblastoma (GBM) is the most common and aggressive form of brain cancer in adults with a dismal
prognosis and limited therapeutic options. Despite significant advancements in the field, cancer
immunotherapy is relatively ineffective in many solid tumors, including GBM. Several factors contribute to
this therapeutic failure in GBM including spatial and cellular heterogeneity, a predominantly pro-tumor
immune microenvironment, and tumor cell-intrinsic immune evasive and suppressive mechanisms.
Characterizing spatially distinct immunosuppressive cell types and the mechanisms they employ to modulate
the anti-tumor immune response represents a promising avenue for targeted therapeutics.
The broad goal of this proposal is to define spatially and phenotypically unique tumor cell mechanisms
that suppress the anti-tumor immune response and are amenable to therapeutic inhibition. This goal will be
achieved by leveraging state of the art sequencing and imaging technologies, advanced in vivo genetic
screening, and robust in vitro and in vivo validation using genetic inactivation techniques.
In Aim 1, spatial proteomics and transcriptomics technologies paired with single-cell RNA-sequencing
to visualize distinct spatial domains with local immune-suppression in patient GBM specimens.
Transcriptional phenotypes of tumor and myeloid cells unique to these domains will be identified and further
analyzed to infer genetic regulators and mechanisms specific to these cells that may be involved in immunesuppression.
In Aim 1, candidate genes defined in the previous aim will be investigated in murine glioma
models. Initially, an in vivo enrichment screen involving CRISPR/Cas9 gene-editing technology will be
performed. In this system, T cells, which are genetically altered to target implanted murine glioma cells but
with a repressed cytotoxic capacity, will transfer Cre recombinase to interacting tumor cells. Notably, these
tumor cells will possess a ere-induced mCherry cassette; therefore, tumor cells that interact with T cells
in the tumor microenvironment will be fluorescently labeled. A gRNA enrichment screen performed on tumor
cells isolated from these mice will reveal genes that are likely involved in mediating tumor-T cell interfacing.
Subsequent in vivo validation studies involving individual inactivation of these genes will determine which are
potently immune-suppressive, defining the top candidates for additional studies focused on in-depth in
vivo and in vitro mechanistic exploration. Further experiments utilizing small-molecule inhibitors or blocking
antibodies against validated targets will be conducted to assess the efficacy of pre-clinical therapeutic options.
These proposed methods of multi-omic spatial analysis. cutting-edge in vivo murine modeling of tumor-immune
interaction. and extensive in vivo and in vitro validation will inform the development of novel therapeutic
strategies to reprogram the GBM immune microenvironment and augment the anti-tumor immune
response. potentially enhancing efficacy of current and emerging immunotherapies.

Public health relevance
Glioblastoma (GBM), a common and highly aggressive brain cancer with a universally fatal prognosis, is characterized by a vast degree of heterogeneity and an immune-suppressive tumor microenvironment influenced by spatial architecture and distinct cellular phenotypes. The work we propose will robustly define regions of localized immune-suppression in GBM and unearth the cellular mechanisms integral to these regions that are involved in modulating the anti-tumor immune response. Favorable results from this proposal will provide a rationale for combining therapeutics targeting genetic regulators of immunosuppressive cell states with other immunotherapies to treat GBM.